High-resolution imaging of the normal and diseased retina

Glaucoma is the second leading cause of blindness worldwide and results in the degeneration of retinal ganglion cell axons and retinal ganglion cell (RGC) death. Strong evidence supports the idea that RGC axons are initially damaged due to structural alterations in the lamina cribrosa within the optic nerve head (ONH). However, the vast majority of supporting studies are based on data from excised eyes. A lack of high- resolution in vivo imaging data of the normal and glaucomatous lamina cribrosa has prevented thorough understanding of the impact of changes in laminar geometry on disease progression in the living eye. This proposed work will test the hypothesis that structural alterations in laminar pores underlie subsequent axonal damage and vision loss in the normal aged eye and eyes with glaucoma. The hypothesis will be examined by pursuing three specific aims. The first aim will measure in vivo changes in laminar pore geometry over the time course of experimental glaucoma in macaque monkeys with a confocal adaptive optics scanning laser ophthalmoscope (AOSLO). These data will be combined with changes in visual function (standard automated perimetry and electroretinography) and retinal nerve fiber layer (RNFL) thickness (using optical coherence tomography) at corresponding time-points to test the hypothesis that laminar pore changes precede axonal and vision loss in experimental glaucoma. The second aim will determine age-related differences in laminar pore geometry in normal living human eyes using the AOSLO and test the hypothesis that laminar pore size increases with age and is associated with small increases in cupping (measured via fundus photography) and decreased RNFL thickness and visual function. The last aim applies the same methods to measure laminar pore geometry in patients with primary open-angle glaucoma. It will test the hypothesis that larger pore sizes and increased cupping occur in eyes with increasing disease severity and are correlated with decreases in RNFL thickness and visual function. This research plan is based on defining procedures and relationships with experimental glaucoma and extending them to human patients to test their clinical significance. It is aligned with the missions of the NEI and NIBIB in that it investigates a potential mechanism underlying a blinding retinal disease and seeks to improve the diagnosis and assessment of glaucoma in human patients via a new application of a biomedical imaging technique (i.e., AOSLO imaging). The approach is innovative because it uses confocal AOSLO imaging to increase the lateral resolution and contrast of laminar images relative to current clinical instruments, thereby allowing laminar pore geometry to be reliably measured in living normal and glaucomatous eyes. The proposed research is significant because it will lead to more sensitive in vivo imaging techniques to examine structural changes and better clarify the etiology of glaucoma. Ultimately, such knowledge will enhance our understanding of the lamina's role in the development and progression of this disease and may provide an earlier marker of structural damage (i.e., laminar pore alteration) in glaucoma.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will use a state-of-the-art high-resolution imaging method to explore the impact of changes in the lamina cribrosa on neuronal damage and vision loss in living eyes with glaucoma. The results of this study will provide a better understanding of the structural properties of the lamina cribrosa in normal and diseased eyes and of the mechanisms responsible for the death of retinal neurons in the glaucomatous and normal, aging retina. They may also result in more sensitive imaging diagnostics that could prevent vision loss via earlier detection of structural damage and better evaluate and track the efficacy of disease treatments. __SpecificAimsTextDelimiter__ Specific Aims Our long-term goal is to develop and apply highly sensitive optical tools to detect and track the development and progression of glaucomatous pathology in the retina. These tools will not only lend insight into the broad mechanisms of glaucomatous degeneration, but will also help to better assess the efficacy of current and future treatments. A variety of mechanical, vascular and glial mechanisms are implicated in the degeneration of retinal ganglion cells (RGCs) and their axons in glaucoma. The lamina cribrosa has been identified as a primary site of damage to RGC axons. Previous work using postmortem tissue and experimental models has shown that structural alterations and disruptions in the lamina cribrosa are associated with disease progression. It is uncertain the extent to which age-related structural changes in the lamina cribrosa and optic nerve head could contribute to optic nerve degeneration in glaucoma. The general lack of high-resolution in vivo imaging data of the lamina cribrosa in normal eyes and during glaucomatous progression has limited our ability to establish how differences and changes in laminar geometry contribute to the pattern of disease progression over time in the same eyes. Here we propose experiments that will capitalize on recent advances in in vivo confocal adaptive optics imaging to determine the impact of changes in the lamina cribrosa on axonal damage and visual function. Specifically, we will apply novel techniques for confocal reflectance adaptive optics imaging to determine how changes in the lamina cribrosa track with axonal insult and vision loss in living eyes of non-human primates with pressure-induced experimental glaucoma and determine differences in laminar geometry in vivo with age (a risk factor for glaucoma) in normal human eyes and in human eyes with primary open-angle glaucoma (POAG). Our approach will lead to more sensitive in vivo imaging diagnostics that may provide earlier markers of structural damage in glaucoma. Specific Aim 1: Test whether changes in lamina cribrosa morphology observed in vivo in experimental glaucoma in non-human primates precede changes in nerve fiber layer thickness and visual function. We will use in vivo confocal adaptive optics imaging to characterize structural changes in the anterior lamina cribrosa during unilateral experimental glaucoma in rhesus macaque monkeys. Pore size and shape, and nearest neighbor distance will be measured longitudinally in eyes with experimental glaucoma and will be compared to the same measures from the same eyes prior to glaucoma and contralateral control eyes. These changes will also be correlated with changes in axonal loss (assessed via retinal nerve fiber layer [RNFL] thickness measurements using spectral domain optical coherence tomography [SD-OCT]) and visual function (assessed with standard automated perimetry and with electroretinograms to measure the light-adapted photopic negative response [PhNR]). Specific Aim 2: Determine differences in lamina cribrosa geometry with age in vivo in normal human eyes. We will use confocal adaptive optics imaging to measure differences in anterior lamina cribrosa pore geometry and density in vivo in normal human eyes over a large range of ages. Pore measurements will be correlated with optic nerve head parameters (such as cupping, diameter of the neural canal opening, and anterior laminar surface height), RNFL thickness and area (assessed using SD-OCT) and visual function (assessed with perimetry and the PhNR). These experiments are expected to reveal whether there is increased cupping and anterior laminar pore alteration with age and if these functional and structural changes correlate with the decreased RNFL thickness observed in normal, older human eyes. Specific Aim 3: Determine differences in lamina cribrosa geometry in vivo in glaucomatous human eyes. Using confocal adaptive optics, we will image and quantitatively measure anterior laminar pore sizes, shapes, nearest neighbor distances, and coverage (pore area/laminar area) in vivo in human patients with different stages of POAG (determined based on visual field testing). We will correlate these measurements with optic nerve head parameters (such as anterior laminar surface height, diameter of the neural canal opening and cupping), RNFL thickness and area (assessed using SD-OCT) and visual function (assessed with perimetry and the PhNR). These experiments are expected to reveal whether and when increases in laminar cupping and pore elongation occur and whether they are associated with decreases in RNFL thickness and functional measures with increasing disease severity.